Advancing Tobacco Regulatory Science to Reduce Health Disparities

ABSTRACT: OVERALL
The US has made decades of progress in reducing cigarette smoking, but notable disparities persist in menthol
flavored product use and in the use of non-cigarette tobacco products, including little cigars, cigarillos, and e-
cigarettes. We propose the U54 Program Project, “Advancing Tobacco Regulatory Science to Reduce Health
Disparities” to address this gap. The Integrative Theme of our UNC TCORS is building the science for
effective regulation of and communication about tobacco products disproportionately used by priority
populations – flavored tobacco products and e-cigarettes. Our integrated set of four Research Projects seek to
understand the impact of regulations and communication campaigns on those disadvantaged by tobacco use
disparities, including Black; lower-socioeconomic status (SES); and lesbian, gay, or bisexual (LGB)
populations; and youth and young adults. Our ultimate goal is to further FDA and NIH efforts to protect public
health through regulation of tobacco products. UNC TCORS’ research will provide essential evidence to guide
the FDA as it implements bans on menthol cigarettes and flavored cigars, develops communication
campaigns, and addresses the youth vaping epidemic. We propose four Specific Aims: 1) Develop and
evaluate the impact of communication campaigns to discourage tobacco product use in diverse populations
(Projects 1, 2, 4); 2) Understand the public health impact of flavored tobacco product bans in diverse
populations and the conditions under which they are most likely to be most effective (Projects 2 and 3); 3) Build
trainees’ capacity to contribute to the field of tobacco regulatory science through training, mentorship, and pilot
funding for a diverse and multidisciplinary group of pre-doctoral fellows, post-doctoral fellows, and early-stage
investigators (Projects 1-4, Career Enhancement Core); 4) Inform FDA regulation of menthol cigarette and
flavored cigar bans and communication campaigns through active dissemination of TCORS scientific findings
(Projects 1-4, Administrative Core). Project 1 will develop a novel communication campaign to discourage
young adult little cigar and cigarillo use. Project 2 will evaluate whether a menthol cigarette ban could be
amplified by a quit smoking campaign to help menthol smokers quit, including Black and LGB smokers. Project
3 will build a microsimulation model to estimate the public health impact of a federal flavored cigar ban on
tobacco use, mortality, and health disparities. Project 4 will test the ability of vaping prevention video ads with
promising features to reduce susceptibility to vaping among youth and young adults. The Research Projects
will receive support from two Cores: Administrative and Career Enhancement (which includes Pilot Research
Projects). Our multidisciplinary group of seasoned regulatory science researchers will provide actionable
information to inform FDA regulations and communication campaigns.

Public health relevance
RELEVANCE: OVERALL Significant progress has been made in reducing cigarette smoking in the United States, but notable disparities persist in menthol cigarette smoking and in the use of non-cigarette tobacco products, including little cigars and e-cigarettes. UNC TCORS will conduct four integrated Research Projects that will inform FDA efforts to communicate more effectively with the public about tobacco products (i.e., little cigars and cigarillos, menthol cigarettes, and e-cigarettes) and identify the public health impact and unintended consequences of an FDA flavored cigar ban. This new evidence will identify specific actions that FDA can implement to reduce existing disparities in tobacco product use.